Patient Oriented Research in Vulnerable Populations with Skin Disease

Project Summary/Abstract
The overarching goal of this proposal is to improve the care of vulnerable populations with skin disease,
including: a) the elderly, and b) racial and ethnic minorities. For elderly patients with skin disease, we will focus
on patterns of medication use, to identify unexplained variations that might highlight opportunities for optimal
prescribing practices. For racial and ethnic minority patients, we will focus specifically on care patterns and
unmet needs of patients with Hidradenitis Suppurativa (HS). This K24 proposal adds to my current research
portfolio by expanding my research focus on the care of vulnerable populations.
The mentorship goals of this proposal are aligned with the research aims. The proposed studies provide
hands-on research training experiences in quantitative and qualitative data collection and analysis for mentees,
and will produce preliminary data for mentees' K, T, and R applications. This application proposes three
incremental studies in my long-term research objective to improve the health of vulnerable populations with
skin disease through my own research and through training a diverse group of patient-oriented researchers.
The project builds directly on my previous research and leverages existing networks, collaborations and
access to leaders in behavioral science and geriatrics, social media and technology.
The specific aims of the proposed research are: 1) to determine patterns of care and medication use among
elderly patients with skin disease, 2) to better understand patterns of care and medication use by race,
ethnicity and gender among patients with Hidradenitis Suppurativa, and 3) to understand the unmet needs of
patients with HS in order to identify opportunities for improving their quality of life (QoL). This research will
employ a mixed-methods approach. Aims 1 and 2 will be achieved by analyzing the data from large national
datasets, including the Health and Retirement Survey (HRS) linked to Medicare and the National Ambulatory
Medical Care Survey (NAMCS). For Aim 3, we will utilize a qualitative approach, conducting focus groups and
cognitive interviews with leaders in the HS community.
This award will ensure that I have sufficient protected time to fully support my mentees, particularly those from
backgrounds traditionally underrepresented in medicine. I am dually trained in epidemiology and dermatology
and have extensive experience with patient-oriented research in dermatology, enabling me to be a successful
mentor for trainees interested in a variety of topics in dermatologic research. The long-term goal of this
research is to expand our knowledge on the care of vulnerable populations with skin disease, so that we can
improve the quality of life and optimize dermatologic care of these patients. This K24 will give me the
opportunity to expand my mentoring and research on these topics and allow me to train the next generation of
dermatologic researchers passionate about improving the lives of vulnerable populations.

Public health relevance
PROJECT NARRATIVE The purpose of this proposed Midcareer Investigator Award is to mentor the next generation of patient-oriented researchers focused on improving the care of vulnerable populations with skin disease. The mentorship goals of this proposal are aligned with the research aims. We will use quantitative and qualitative methods to study patterns of care and unmet patient needs, in order to highlight opportunities for improved care for two vulnerable groups of patients: a) the elderly and b) racial and ethnic minorities.